Coupling of transcription elongation and termination with pre-mRNA processing

Project Summary/Abstract
The production of messenger RNA (mRNA) is the primary event in gene expression where genetic
information is transfered from the gene’s DNA into a disposable RNA copy. Corruption of this
process is a hallmark of many diseases including cancer. mRNA synthesis requires not only
synthesis of an RNA transcript but maturation of that transcript by 5’ capping, excision of introns
and splicing of exons and 3’ end formation by cleavage and polyA tail addition. The mRNA
processing steps that radically transform the primary transcript occur largely co-transcriptionally;
that is to say the substrate of mRNA processing is the growing nascent RNA that is extruded by
an RNA polymerase II (pol II) molecule at rates of 500-5000 bases/min. Our working model is that
synthesis and processing of a mRNA precursor are carried out in an integrated fashion within a
dynamic 'mRNA factory' complex that includes both RNA polymerase and processing factors
some of which make direct contacts with the pol II C-terminal domain (CTD). The goal of our work
is to understand how growth of the RNA chain by transcription is coordinated with its folding into
RNA secondary structures, its association with RNA binding proteins, and its maturation by
splicing and 3’ end formation. These important features of nascent RNA metabolism are all
affected by how fast the RNA chain grows. Therefore it is important to discover how the speed of
pol II is controlled as it travels along genes. When pol II completes its journey to the end of the
gene, the highly stable transcription elongation complex must be actively disassembled to recycle
the enzyme and prevent it from invading neighboring genes. We will investigate how the process
of transcription termination is achieved in carefully controlled ways at the 3’ ends of genes and
also within genes where termination can occur “prematurely”. We will use genetic and genomic
approaches in human cells to investigate these three Key Challenges:
I. What is the relation between pre-mRNA processing, nascent RNA folding, RNA
binding protein (RBP) binding, and transcription elongation?
II. How is the speed of transcription elongation regulated?
III. What mechanisms terminate pol II transcription within genes and downstream of
genes?

Public health relevance
Project Narrative Many diseases including cancers are directly caused by the misexpression of genetic information that can occur by corruption of multiple steps in the pathway that makes messenger RNAs. A major point of vulnerability in this pathway is at essential steps in mRNA maturation by splicing and cleavage/polyadenylation; steps that must be properly coordinated with synthesis of these RNAs. The work in this proposal will help uncover how the intricate coordination between synthesis and maturation of mRNAs works in healthy cells and how it might go wrong in diseased cells.